Primary care involvement in End Stage Renal Disease Seamless Care Organizations (ESCOs) and the quality and costs of care for patients on chronic dialysis

PROJECT SUMMARY
End-stage renal disease (ESRD) patients on chronic dialysis are extremely costly to manage, accounting for
7% of Medicare spending, yet representing 1% of the population. Most of their costs stem from management of
the multiple and severe comorbidities that are highly prevalent in this group, with mortality rates 20-fold higher
than patients of similar age and sex in the general population. To address these issues, Medicare established
in 2015 a model of specialty-oriented accountable care organizations (ACOs), known as ESRD Seamless Care
Organizations (ESCOs). Constituted by dialysis centers and nephrologists, ESCOs accept responsibility for
costs and quality of care of aligned beneficiaries in exchange for potential shared savings. A report on the first
performance year demonstrated $75 million in savings. With promising results to date, the program is being
rapidly expanded. However, much remains unclear about how these savings were achieved and what impact
they will have on clinical outcomes. Not all the ESCOs achieved savings, and there was over six-fold variation
in savings per beneficiary across those that did. There was also substantial variability in performance on
quality measure targets, many of which focused on aspects of routine or preventive care beyond dialysis care.
These variations may, therefore, be plausibly explained by the extent to which ESCOs successfully involve
primary care physicians (PCPs) in the care of their patients–a decision left to the discretion of individual
organizations. PCPs may be particularly effective in the management of this population, given their experience
and expertise with coordination of care, their accessibility, and their generally more holistic view of the patient.
Thus, an ESCO’s success at curbing spending and improving outcomes for its aligned beneficiaries may
depend on its ability to increase interactions between nephrologists and PCPs. Regardless, it remains unclear
whether ESCOs offer any added benefit over older primary care-oriented ACO designs like the Medicare
Shared Savings Program (MSSP), in which 20% of Medicare beneficiaries on chronic dialysis currently receive
their care. We propose a study with the following three Specific Aims: 1) To assess ESCO effects on
interactions among nephrologists and PCPs or other specialists 2) To assess the impact that increased PCP
involvement has on ESCO financial performance and clinical outcomes and 3) To compare the costs and
outcomes of care for chronic dialysis patients as a function of PCP involvement in ESCOs, versus MSSP
ACOs. Findings from this work will provide critical information to guide ongoing efforts at reorganization of
health care for the dialysis population with the goal of improving the efficiency and quality of care delivered.

Public health relevance
PROJECT NARRATIVE At a half million patients and counting, the chronic dialysis population includes some of the costliest and sickest patients in the United States. Findings from this proposal will help identify better ways to provide care for these patients, in order to reduce spending and improve their clinical outcomes.